The role of neurotrophins in the maintenance and function of MF-CA3 synapses

PROJECT SUMMARY/ABSRACT
The hippocampus has a well-established role in the encoding and recall of spatial memory. At the center of the
hippocampal circuit are dentate gyrus (DG) granule cell mossy ﬁber (MF) to CA3 pyramidal neuron synapses.
MF-CA3 synapses have been found to play a key role in learning and memory. However, little is known about
the regulation of development and function of these highly plastic synapses. Neurotrophins, such as BDNF and
NT3, play a critical role in neuronal development and function. BDNF is well characterized in its role in the CNS
however, NT3 has long been forgotten. Both BDNF and NT3 and their receptors, TrkB and TrkC, respectively
are located at MF-CA3 synapses. Results from our lab suggest the ablation of NT3, encoded by Ntf3, in the DG
alone is sufﬁcient to reduce synaptic transmission and induce contextual fear memory deﬁcits. Despite their
colocalization in the DG, initial results suggest independent or synergistic roles of BDNF and NT3 and MF-CA3
synapses. It is left to be determined what are the independent or coordinated roles of BDNF and NT3 in
development and function at MF-CA3 synapses. My data indicates the ablation of Bdnf in the DG results in basal
synaptic transmission deﬁcits. Currently, knowledge about neurotrophins at MF-CA3 synapses is limited to
BDNF's role in long-term potentiation, nearly nothing is known about how NT3 acts on MF-CA3 synapses. Thus,
my preliminary observation offers insight into the possible mechanism underlying synaptic plasticity induced
learning and memory. The overarching hypothesis is that BDNF and NT3 work independently or synergistically
at MF CA3 synapses to promote development and function. To investigate this hypothesis, I will employ three
integrated aims to dissect in vivo alterations at MF-CA3 synapses caused by the ablation of Bdnf or Bdnf and
Ntf3 from DG granule cells. From Aim 1, I will determine how BDNF and NT3 regulate structure at MF-CA3
synapses. I have generated DG speciﬁc knock out of Bdnf (Bdnf-cKO) and Bdnf and Ntf3 (Bdnf/Ntf3-dcKO) using
the Pomc-Cre mouse line. To analyze MF axon terminals and CA3 dendric spines called thorny excrescence
(TE), I utilize AAV stereotaxic injection to label neuronal structures. Additionally, I utilize expansion sample
preparation to image synapse immunostaining at super resolution and perform 3D reconstruction to analyze
individual synapses. Finally, I will perform electron microscopy to reveal detailed structure at MF-CA3 synapses.
From Aim 2, I will characterize how the ablation of Bdnf affects the function of MF-CA3 synapses by employing
behavioral assay to understand to what extent of spatial and contextual memory deﬁcits in Bdnf-cKO mice. From
Aim 3, I will perform single nuclei RNA sequencing (snRNA-seq) on DGGCs to elucidate the mechanism by
which BDNF regulates the active zone of MF axon terminals. The outcomes of the proposed research will
elucidate the roles of two neurotrophins in the function of synaptic transmission and memory.

Public health relevance
PROJECT NARRATIVE The mechanism of learning and memory is widely studied, however, the detailed function of neurotrophins BDNF and NT3 in the hippocampus remains limited. This proposed research aims to elucidate the role of BDNF and NT3 in MF-CA3 synapse development, maintenance and function. Research proposed will enhance our understanding of the mechanism underlying learning and memory at MF-CA3 synapses.